Deciphering the Pathogenesis of EHEC Infection and the Effects of Bacteria-Based Therapies Using Comparative Gut-on-a-Chip

PROJECT SUMMARY
This NIH ORIP R21 award application describes a 2-year plan designed to allow us to investigate
pathophysiology of Enterohemorrhagic Escherichia coli (EHEC) infection in translational and comparative canine
and human in vitro models. Investigation of the gastrointestinal injuries caused by EHEC and the development
and assessment of therapeutic interventions have been hampered by the lack of translatable in vitro models that
effectively reproduces the typical human colonic disease that progresses to bloody diarrhea and hemolytic
uremic syndrome (HUS). The EHEC infection in dogs takes very similar clinical courses to that in humans as
canine EHEC infection can naturally lead to mild to severe forms of EHEC infection as well as HUS. In carrying
out the proposed research, development of both canine and human EHEC models will be accomplished while
utilizing our expertise in veterinary gastroenterology, intestinal stem cell biology, microbiome, and microfluidic
organ-on-chip technology. Our proposed study is a high-risk project because canine in vitro modeling of EHEC
infection has never been performed before in an organ-chip platform. However, we believe our previous work
makes this study highly feasible to develop canine and human EHEC Chips by incorporating colonoids,
microbiome, immune cells, EHEC, and bacteria-based treatments into the physiological model. Specifically, Aim
1 will allow development of canine and human EHEC Chips and assessing the contribution of microbiome in the
disease pathogenesis while mapping host responses by utilizing single-cell level multi-omics (especially
genomics and transcriptomics) and RNA in situ hybridization. Aim 2. will allow assessment of immune
contribution in the pathogenesis. Aim 3. will allow further assessment of preventative or therapeutic effects of
two well studied bacteria (E.coli Nissle 1917 and MccPDI producing E. coli) on EHEC Chips. Consistent with the
ORIP’s mission statements promoting veterinary scientists to employ their expertise in comparative medicine to
investigate human diseases, my research will allow me to use my expertise in comparative gastroenterology as
well as in primary stem cell culture to investigate alterations in intestinal homeostasis relevant to EHEC infection.
The results generated in this proposal have direct implications for in vivo canine EHEC models and ultimately to
human EHEC patients, since they will utilize donor-derived colonoids in the experimental designs and provide
new insights into transcriptomic alterations in initiating, propagate, or ameliorate the EHEC infection. Our findings
on the species similarities and differences in host responses can be applied to various chronic conditions that
have been associated with intestinal dysbiosis that occur in both human and dogs (i.e., Colorectal Cancer,
Diabetes Mellitus, and Alzheimer’s Disease, to name a few). In summary, the proposed study in this application
will allow us to map the host-EHEC crosstalk as well as the effect of bacteria-based therapies by leveraging the
single-cell multi-omics analysis, which may lead to a broader impact on uncovering the underlying disease
mechanism and developing new preventative or therapeutic anti-EHEC therapy.

Public health relevance
PROJECT NARRATIVE Investigation of the gastrointestinal injuries caused by Enterohemorrhagic Escherichia coli (EHEC) and the development and assessment of therapeutic interventions to prevent disease following infection have been hampered by the lack of translatable animal models that effectively reproduces the typical human colonic disease that progresses from acute colitis to system illness. My research proposes to develop a translational and comparative canine and human EHEC Chip by integrating a microfluidic gut-on-a-chip and biopsy-derived colonoids to recapitulate host (intestinal epithelium, microbiome, and immune cells)-EHEC crosstalk. The ultimate goal is to map the host-EHEC crosstalk as well as the effect of bacteria-based therapies by leveraging the single-cell multi-omics analysis, which may lead to a broader impact on uncovering the underlying disease mechanism and developing new preventative or therapeutic anti-EHEC therapy.